Regulation of bidirectional transport of the nucleus by adapter proteins

PROJECT SUMMARY
The cell nucleus is bi-directionally transported and positioned in a cell cycle specific manner, a process that is
important for cell cycle control as well as brain and muscle development. The importance of nuclear positioning
for brain and muscle development is underscored by the fact that human disease mutations of proteins
engaged in the transport of the nucleus cause severe brain and muscle development diseases, including
amyotrophic lateral sclerosis (ALS), hereditary spastic paraplegia and spinal muscular atrophy, which is the
most common genetic cause of death in infants. Yet, it is unknown how teams of opposing motor complexes
collaborate to achieve correct timing, directionality and velocity of transport. Notably, the interactions of
opposing motors with cargoes have not been characterized by biochemical or structural methods as proposed
here. The nuclear pore complex protein Nup358 provides recruitment sites at the nuclear envelope for the
opposing motor complexes dynein and kinesin-1, which can bind simultaneously and facilitate bi-directional
positioning of the nucleus along microtubules. This pathway is important for faithful chromosome segregation
and essential for a fundamental process in brain development that is required for brain progenitor cells to
differentiate to neurons and other cell types. Dynein adapters such as Bicaudal D2 (BicD2) have key roles in
transport, as they select cargoes and are required to activate dynein for processive motility; however, the
underlying molecular mechanism is unknown.
We plan: 1) To establish how dynein motility is modulated by dynein adapter/cargo complexes and by kinesin-
1. 2) to establish a structural basis for recognition of the cell nucleus as cargo by dynein adapters. 3) To
establish whether dynein and kinesin-1 are recruited in a cooperative manner to Nup358 at the nucleus, i.e.
whether binding of the first motor changes the affinity for the second motor. We plan to establish how
BicD2/cargo complexes activate dynein for processive motility. Furthermore we plan to assess how kinesin-1
modulates motility of the dynein/BicD2/Nup358 complex.
Our approach combines NMR spectroscopy, X-ray crystallography and biophysical methods, which are
integrated with single-molecule processivity assays with intact dynein and kinesin-1 motors. Results will
establish a structural basis for cargo selection by BicD2. Our study serves as a model system to understand
how cargo adapters regulate the motility and directionality of cargo transported bi-directionally by both dynein
and kinesin-1, which is important as these motors facilitate a vast number of cellular transport events that are
essential for chromosome segregation, signal transmission at synapses, brain and muscle development. More
specifically, results will establish how correctly timed bi-directional transport of the nucleus is regulated, which
is crucial for cell cycle control, muscle and brain development. Mutations of proteins of these pathways cause
devastating neuromuscular diseases, and results will help devise therapies for these diseases.

Public health relevance
PROJECT NARRATIVE We plan to establish how the bi-directional transport of the nucleus is orchestrated, which is important for normal brain and muscle development. Human disease mutations of proteins participating in the transport of the nucleus cause severe brain and muscle developmental defects, including amyotrophic lateral sclerosis (ALS), hereditary spastic paraplegia and spinal muscular atrophy, which is the most common genetic cause of death in infants. Results will establish regulatory mechanisms for dynein and kinesin-1-dependent transport, which can be targeted to treat these devastating neuromuscular diseases.